A Conserved RNA Binding Protein Regulates RNAs Critical for Neurodevelopment

PROJECT SUMMARY
Intellectual disability is a common neurodevelopmental disorder characterized by limited intellectual functioning
and impaired adaptive behavior. The clinical heterogeneity of intellectual disability is reflected by extreme genetic
complexity, leaving etiology unresolved in over 60% of diagnosed patients. Underscoring this complexity, lesions
in more than 700 genes have been linked to intellectual disability. Critically, emerging evidence suggests that
this diverse group of these genes converge on a limited set of molecular pathways, principally those critical for
brain development and function. This convergence suggests that studies of monogenic, experimentally tractable
forms of intellectual disability can provide molecular insight into mechanisms common to all forms of the disease.
Interestingly, many of the genes linked to intellectual disability encode RNA binding proteins (RBPs) that play
critical roles in post-transcriptional regulation of gene expression. My mentors’ labs co-discovered one such
monogenic form of intellectual disability caused by loss of function mutations in the ubiquitously expressed RBP
ZC3H14. To discover why mutations in the ZC3H14 gene impair brain function, we have developed an
experimentally tractable model of ZC3H14 loss by deleting the ortholog, Nab2, in the fruit fly Drosophila
melanogaster. This work has revealed that Nab2 is expressed in all cells but required specifically in neurons
within the developing nervous system to support axon guidance, locomotion, and olfactory memory. However,
the identity of ZC3H14/Nab2-regulated RNAs as well as mechanisms that elevate ZC3H14/Nab2 function in
neurons remain elusive. Recently, my labs have uncovered evidence for a novel role of Nab2 as a regulator of
alternative splicing through inhibition of N6-methyladenosine (m6A) deposition on a subset of neuronally enriched
mRNAs, representing a critical layer of epitranscriptomic regulation of gene expression during neuronal
development. Thus, I will test the hypothesis that Nab2 governs m6A-dependent expression of key neuronal
targets by binding their pre-mRNA transcripts and inhibiting m6A hypermethylation to govern proper brain
morphology and function here by focusing on one Nab2-regulated transcript, trio, which displays aberrant intron
retention upon loss of Nab2. The Trio protein is conserved in vertebrates, the TRIO gene is mutated in a dominant
form of human intellectual disability, and Trio plays a key role in axon guidance and neuronal morphology. The
Specific Aims of this project are to: 1) define the role of Nab2 as a regulator of m6A-dependent expression of
neuronally-enriched transcripts; and 2) examine how Nab2-dependent regulation of Trio expression governs
development of axon tracts in the Drosophila mushroom body, an analog of the hippocampus that supports
olfactory and gustatory memory. Successful completion of the proposed Aims will provide insights into an
apparently conserved pathway linking Nab2 to Trio expression through a neuron-specific role in m6A-regulated
splicing, uncovering more general links between m6A, splicing, and neurodevelopmental defects in humans. The
proposed collaborative research project will provide me with an optimal training experience.

Public health relevance
PROJECT NARRATIVE Intellectual disability, characterized by an I.Q. less than 70 and significant impairments in intellectual and adaptive behavior, affects approximately 1-3% of the world population. Despite the heterogeneous and genetically complex nature, recent studies have led to the discovery that many genes linked to intellectual disability converge on a limited set of molecular pathways, suggesting that distinct intellectual disabilities are unified by common underlying molecular dysfunctions. Here we utilize the fruit fly Drosophila as a system to model a heritable form of intellectual disability by exploring the intersection of specific factors and RNA modifications to define molecular mechanisms underlying intellectual disability disease pathogenesis.